Targeting PI3Kalpha beta and the ErbB family of protein-tyrosine kinases in cisplatin-resistant head and neck squamous cell carcinomas (HNSCC)

PROJECT SUMMARY:
The mortality rate for advanced head and neck squamous cell carcinoma (HNSCC) remains very high due to
cancer recurrence and metastasis. Cisplatin is the most commonly used anti-cancer drug for treatment of
recurrent and metastatic HNSCC, but the majority of patients will eventually develop resistance to this treatment
and die within one year. Therefore, there is an urgent, yet still unmet, need for improved therapies for cisplatin-
resistant HNSCC. A major advancement in the treatment of advanced HNSCC in the past 20 years has been
the use of the FDA-approved EGFR antibody, Cetuximab. Patients respond well to the Cetuximab-based
combination therapies, but they result in only 2-3 months improvement in overall survival. Abnormal activation
of key survival pathways through compensatory mechanisms often leads to therapeutic failure of cisplatin and
EGFR inhibitors. A most important downstream target of EGFR in head and neck cancer is PI3K. EGFR and
other receptor proteins activate PI3K (PI3Kα, PI3Kβ, PI3Kγ, and PI3Kδ), which then initiate activation of Akt and
mTOR to promote tumor growth, metastasis, and therapy resistance. In fact, PI3Kα mutation and amplification
was found in more than 30% of tumors in patients. Therefore, PI3K/Akt/mTOR is a most attractive therapeutic
target in HNSCC. However, although many pan- and isoform-specific PI3K inhibitors have been identified, none
have been effective for therapeutic use in the clinical setting due to poor effective results and intolerable toxicity
caused by the pan-PI3K inhibitors. Thus, it is urgent to find effective PI3K inhibitors for HNSCC therapy. We
recently explored simultaneous blockage of ErbB family and PI3K pathways. We used PI3Kα/δ inhibitor
Copanlisib, recently approved by the FDA for treatment of elapsed/refractory follicular lymphoma, and pan-ErbB
family inhibitor Afatinib, and found that the combination completely blocked PI3K/Akt/mTOR pathways and
significantly suppressed cell proliferation, survival, migration, and invasion in vitro, as well as xenograft tumor
formation in animals. Our data suggest a new potential therapeutic strategy that targets the PI3Kα/δ and ErbB
family to treat cisplatin-resistant HNSCC. To test our hypothesis, we will: (1) determine the significance and
requirement of PI3K isoforms to regulate activation of the Akt/mTOR pathway, and tumor growth, metastasis,
and resistance to EGFR inhibitor; (2) analyze the FOXO3a-dependent and independent up-regulation of HER3
upon treatment with different PI3K inhibitors and the role(s) of HER3 to confer PI3K inhibitor resistance; and, (3)
discover the therapeutic potential of the ErbB family and PI3K to co-target cisplatin-resistant HNSCC treatment
in multiple mouse models. Completion of this project will provide important insights into how to effectively treat
cisplatin-resistant metastatic HNSCC.

Public health relevance
PROJECT NARRATIVE: In order to develop novel therapies for cisplatin-resistant head and neck squamous cell carcinoma (HNSCC), we must first identify the crucial survival pathways that regulate cisplatin-resistant HNSCC. This proposal tests the hypothesis that the ErbB family and downstream target, PI3K, are the crucial drivers and therapeutic targets of cisplatin-resistant HNSCC through their functional interactions to promote tumor growth and metastasis. Thus, this work has great potential to significantly expand our understanding of how HNSCC develops resistance to ErbB family and PI3K inhibitor treatments, as well as provide new therapeutic options to more effectively treat patients with cisplatin-resistant HNSCC.